Regulation of mitochondrial DNA homeostasis and neuroinflammation by Fascin in Alzheimer’s Disease

Project Summary/Abstract
Alzheimer’s disease (AD), the most common neurodegenerative disorder, affects one in ten people age
65 and older. Due to limited understanding of mechanisms underlying AD pathogenesis, there is no effective
treatment for this devastating disease. The goal of this application is to investigate an unexpected role for
actin bundling protein Fascin in regulating mitochondrial nucleoid DNA (mtDNA) homeostasis, oxidative
phosphorylation (OXPHOS), mitochondrial oxidative stress, neuroinflammation, and neurodegeneration, as
well as how dysregulation of these processes contributes to AD pathogenesis.
Fascin is an actin bundling protein essential for the cross-linking of actin filaments into compact and rigid
bundles. The current paradigm posits that Fascin promotes cell migration and tumor invasion by generating
protrusive membrane structures such as filopodia. We recently made the surprising finding that depletion of
Fascin disrupts mitochondrial F-actin bundling, which in turn causes abnormal mitochondrial respiratory
complex biogenesis and impaired mitochondrial OXPHOS, suggesting a novel role of Fascin in the regulation
of mitochondrial function. Mechanistically the mitochondrial dysfunction in Fascin depleted cells was due to
increased mtDNA aggregation and leakage. Given that mtDNA can robustly induce inflammasome activation
and inflammatory cytokine expression, Fascin deficiency may play an unexpected role in causing
neuroinflammation. Importantly, we found that Fascin is cleaved into a 37kDa functionally dominant-negative
form in the brains of AD patients and AD mouse models. Virus-mediated expression of Fascin in AD mouse
hippocampus mitigated disease symptoms. In addition, Fascin knockout mice we generated showed profound
mitochondrial defects and significant loss of neurons in the brain. Based on these preliminary data, we
hypothesize that Fascin controls mitochondrial function and mtDNA homeostasis in the brain. Fascin
functional deficiency in AD leads to significant mitochondrial defects, neuroinflammation and
neurodegeneration. To test the hypothesis, in Aim 1 we will define the role of Fascin in regulating
mitochondrial function, mtDNA homeostasis, neuroinflammation and neuronal cell death in the mouse brain in
vivo. In Aim 2 we will investigate the functional deficiency of Fascin caused by proteolytic cleavage during the
course of AD pathogenesis using brain tissues from AD patients and mouse models, and to elucidate
mechanisms underlying how Fascin functional deficiency causes mtDNA leakage, oxidative stress,
neuroinflammation, and degeneration. In Aim 3 we will study the effects of transgenic expression of Fascin on
alleviating AD pathological phenotypes and disease symptoms in mice.
Successful completion of the proposed studies will reveal Fascin’s novel role in regulating mitochondrial
function, mtDNA homeostasis, neuroinflammation and neurodegeneration. Investigating Fascin functional
deficiency in AD will help understand disease pathogenic mechanisms and facilitate therapeutic development.

Public health relevance
Project Narrative Alzheimer’s disease (AD) is the most common neurodegenerative disorder. This project aims to investigate an unexpected role for actin bundling protein Fascin in regulating mitochondrial function, neurodegeneration, and AD pathogenesis. These studies will provide new insights into the function of Fascin in the brain under physiological and AD disease conditions, and facilitate the development of new therapeutic approaches for AD and other neurodegenerative disorders.